Optimizing early phonological awareness instruction to support reading and spelling acquisition

Project Summary/Abstract
Reading difficulties continue to be a pervasive public health issue. Many children, particularly those from
marginalized populations, experience reading difficulties due to underdeveloped phonological awareness –
and, specifically, phonemic awareness. Although decades of basic research have established phonemic
awareness as causally related to reading acquisition as well as a developmental progression from phonological
sensitivity to phonemic awareness, we know much less about how or when to support phonological
awareness development in children. Our long-term goal is to optimize phonological awareness intervention as
a means of preventing reading difficulties and disparities. Our short-term goal is to complete two randomized
controlled trials that inform such optimization through addressing current scientific controversies around the
content, timing, and goals of phonological awareness intervention. In the randomized controlled trials, we
evaluate three interventions (phonological sensitivity + phonemic awareness, phonemic awareness only,
delayed phonemic awareness), which vary in the linguistic units targeted but are carefully equated on content
and/or instructional time, for their impact on children’s phonemic awareness, reading, and spelling skills
relative to each other and to a control condition; we also consider whether impacts differ based on when and to
whom intervention is provided. Participating preschool and kindergarten children contribute screening, pretest,
midtest, posttest, and longitudinal data to address four aims: (Specific Aim 1) Determine the relative impact on
phonemic awareness, and subsequent reading and spelling development, of intervention that (a) initially
targets phonological sensitivity or (b) directly targets only phonemic awareness, (Specific Aim 2) Determine the
relative efficacy of these two approaches when intervening during preschool or kindergarten, (Secondary Aim
3) Examine whether the impact of the two approaches is differential based on children’s initial phonological
skills and alphabet knowledge as well as language variation, socioeconomic status, and race/ethnicity, and
(Secondary Aim 4) Explore whether a transition point can be identified as to when phonemic awareness
intervention is most likely to be efficacious. The results will contribute to both basic science concerning the
development of phonological awareness and its contribution to reading and spelling acquisition as well as
translational efforts. With respect to the latter, results will inform learning standards, instructional
recommendations, and intervention design to better align these with the scientific evidence base and thereby
improve prevention and intervention for reading difficulties.

Public health relevance
Project Narrative This study addresses efforts to improve academic, economic, and health outcomes by preventing reading difficulties via phonological awareness intervention. The study aligns with NICHD CBDD priorities to conduct basic and translational research that optimizes interventions and thereby prevents negative public health outcomes. Specifically, our findings will inform the content, timing, and goals of phonological awareness intervention to increase effectiveness and efficiency.